COMPARISON OF THE EFFECTS OF TWO METHODS OF SPINAL IMMOBILIZATION ON RESPITORY

The purpose of the study is to determine the effect of two different types of spinal immobilization devices on respiratory effort in the older adult, aged 65-75.